Understanding Hirschsprung disease using hPSC-derived models of the enteric nervous system

Abstract
Hirschsprung Disease (HSCR) is a severe congenital anomaly within the gastrointestinal (GI) tract, resulting
from the absence of intrinsic nerves in the distal bowel, a condition medically termed as aganglionosis. HSCR
arises from mutations in numerous genes that lead to defects in the enteric nervous system (ENS)—an intricate
network of neurons and glial cells that governs the GI motility and secretory functions. While surgical resection
remains the primary treatment, it often fails to rectify persistent GI dysfunctions, underscoring the need for a
comprehensive understanding of the disease pathogenesis beyond the current insights provided by animal
models. Building upon established protocols for differentiating human pluripotent stem cells (hPSCs) into enteric
neurons and glial cells, this research aims to systematically explore the impacts of known HSCR mutations on
ENS development, from cell fate specification to migration and neuronal maturation. Employing single-cell
transcriptomics, functional assays and transplantation experiments in mouse models, the study seeks to unravel
mutation-specific effects on ENS function and identify therapeutic targets capable of ameliorating the cellular
phenotypes associated with HSCR. The anticipated outcomes promise to drive the inception of broad-spectrum
therapeutic strategies, enabling the development of personalized treatment modalities based on the unique
genotypic and phenotypic presentations of HSCR, potentially improving quality of life and outcomes for affected
individuals.

Public health relevance
Project Narrative This project investigates Hirschsprung Disease (HSCR), a severe congenital condition in the gastrointestinal tract caused by defects in the enteric nervous system (ENS). Using human pluripotent stem cells, the study will dissect how specific gene mutations affect ENS development and function. Insights from this research will detail the cellular consequences of HSCR mutations, contributing to a foundational understanding of the disease and pave the way for future innovations in HSCR therapeutic approaches, emphasizing the potential for improved patient management strategies.